Development of Apo Mimetic Peptides for the Treatment Cardiovascular Disease

In the past year, we have made significant progress on our work related to apolipoprotein mimetic peptides. In regard to apoA-I mimetic peptides, we completed all the necessary studies and a clinical trial to start a Phase Ia study on the 5A mimetic peptide. For our project related to apoC-II mimetic peptides, we published a report in Science Translation Medicine showing that it lowers plasma triglycerides not only by activating LPL but also by antagonizing apoC-III. Using novel chemistry to stabilize helix formation, we have recently synthesized peptides that are about the half the length of our previous apoC-II mimetic peptides and are resistant to proteolysis.